Community Engagement Core

Summary. U.S. communities that are marginalized as a result of historic and ongoing injustices experience
persistently inequitable rates of adverse health outcomes. These communities will also disproportionately
experience climate-induced health impacts as climate change causes extreme temperatures, weather events,
and poor air quality. The community health centers (CHCs) serving these communities are uniquely positioned
to intervene to address these impacts. The perspectives of CHC patients, providers, and staff and other
community organizations working for climate impact mitigation are critical to developing strategies that CHCs
can implement to prepare for and mitigate climate-induced health impacts in the populations they serve. To
solicit these perspectives, the Community Catalyst CCHRC’s Community Engagement Core (CEC) will
conduct extensive community engagement activities foundational to the CCHRC’s central theme of identifying
effective CHC-led interventions to address climate-induced health impacts. The CEC will create, engage, and
continuously evaluate a transdisciplinary multidirectional learning community with expertise in diverse domains
relevant to such impacts, through a Community Advisory Board (CAB) comprised of three interactive advisory
committees (health system stakeholders, scientific experts, and community organizations focused on climate
change mitigation and environmental justice). CAB committees will collaborate to identify interventional
strategies that CHCs may implement to prepare for and mitigate climate-induced health impacts. Concurrently,
we will collect and analyze observational, interview, and focus group data from patients and staff at six diverse
CHC organizations to identify the mechanisms through which CHC-led interventions could mitigate these
impacts. The CEC will work closely with the Research Program Core (RPC), as the CAB members and CHC
patients and staff will react to the RPC’s Aims 1-2 results on asthma and hypertension exacerbation associated
with extreme climate events in CHC populations, and their emergent questions will inform the RPC’s Aim 3
analyses. CEC activities will yield a community-generated agenda for future CCHRC research on CHC
interventions to mitigate climate-induced health impacts and the support that CHCs need to sustainably
implement proven interventions. The CEC will disseminate and advance this agenda in collaboration with the
CAB and the RPC using diverse mechanisms, including supporting the development of proposals for external
funding led by CCHRC-cultivated community-researcher partnerships. This agenda, together with the results of
the RPC Aim 3 analyses, will inform the development of CHC-prioritized future CCHRC research.